CHIME Analysis Core (AnC)

Project Summary for the RCMAR CHIME Analysis Core
The primary mission of the CHIME analysis core (AnC) is to provide data collection and analysis support to
RCMAR Scientists and to promote new lines of investigation that will address our theme of “Developing,
Adapting and Evaluating Interventions to Improve the Health of Minority Elders”, which incorporates elements
of two of the RFA research objectives: i) identify and develop solutions to eliminate health disparities and
health inequities in the growing population of older adults, and ii) improve the health and well-being of older
adults. The three specific aims of the AnC are to: 1) Provide comprehensive methodological and statistical
support to CHIME RCMAR Scientists including qualitative data methods (e.g., focus groups and cognitive
interviews) and quantitative data methods for developing, implementing, analyzing, and disseminating
organizational and individual behavioral interventions, 2) Provide exposure to state-of-the-science analytic
methods and approaches for the analysis of secondary data to understand factors that affect population aging,
particularly for minorities, 3) Assist RCMAR Scientists with use or modification of existing measures, or
developing new behavioral or social measurement tools for use in mid- life or elderly populations, particularly
those of low socio-economic status or other societal disadvantages. The AnC will connect RCMAR Scientists
with the new Methods Centers at the RAND Pardee Graduate School, the online UCSF Implementation
Science Curriculum, and a qualitative data analysis course led by AnC co- director Dr. Gery Ryan; each of
which will support the development of research addressing both focus areas (i) and (ii). In addition, the AnC
will provide support to all RCMAR Scientists in addressing identified measurement and methods issues by
matching Core and/or consulting faculty with RCMAR Scientists based on the methodologic expertise of the
faculty and the needs of the pilot studies. The AnC will assess the methodological needs from scientists on a
regular basis to provide resources and training opportunities to meet those needs. The AnC will also provide
assistance with data management and statistical and programming support as needed to facilitate high-quality
research addressing the theme of the Center.